Understanding the link between sociocultural and biological factors to brain health across race & ethnicity in midlife

PROJECT SUMMARY/ABSTRACT
Black and Latinx in the U.S. experience greater brain aging and increased risk for Alzheimer’s disease and
related dementias (ADRD) than Whites. The weathering hypothesis, originally proposed to explain the premature
decline of health experienced by Black women exposed to stress, social disadvantage, structural racism, and
discrimination, may help explain the faster brain aging and racial/ethnic disparities in ADRD in late life among
older Black and Latinx people. Identifying potential targets for interventions to reduce disparities in brain health
in the diverse aging population is of critical importance to the rapidly expanding aging population. Biological
aging, the progressive loss of system integrity that occurs as we age is proposed as a modifiable process
mediating this health inequality. Further, previous studies show that ADRD pathology begins as early as midlife,
thus, it is critical to evaluate these relationships in midlife, a time that may be the most critical period for
intervention. This proposal leverages data collected from the Offspring Study of Mechanisms for Racial
Disparities in ADRD—a longitudinal study of racially/ethnically diverse middle-aged adults with MRI, blood
assays, and interview data. The primary goals of this K99/R00 proposal are to determine the relationship
between advanced biological aging and MRI biomarkers in racially/ethnically diverse middle-aged adults and to
characterize the links between lifecourse socioeconomic status (SES), advanced biological aging, and MRI
biomarkers of aging and ADRD.
This K99/R00 proposal lays the foundation for an independent research career focused on understanding the
causal pathways linking environmental, sociocultural, and biological factors to disparities in brain health across
race/ethnicity. Together, the research and training plans will allow the applicant to (1) develop expertise in using
multiple modalities to understand biological and brain aging; 2) master causal inference modeling, with special
emphasis on multigroup analyses that compare relationships by race/ethnicity; 3) broaden knowledge base of
health-defining sociocultural factors in midlife; and 4) establish a strong foundation in theory and research related
to cultural influences on brain health. These experiences will supplement the applicant’s strong existing
background in cognitive neuroscience and cognitive aging. Results from this study may point to new sources of
racial/ethnic disparities in brain aging and ADRD that could be future targets for intervention, and help to validate
accessible, blood-based targets for monitoring or prevention of ADRD among diverse communities of middle-
aged adults.

Public health relevance
PROJECT NARRATIVE Identifying potential targets for interventions to reduce disparities in brain health in the diverse aging population is of critical importance to the rapidly expanding aging population. This proposal leverages data collected from the Offspring Study to characterize the links between lifecourse socioeconomic status (SES), advanced biological aging, and MRI biomarkers in racially/ethnically diverse middle-aged adults. Results from this study may point to new sources of racial/ethnic disparities in MRI that could be future targets for intervention, and help to validate accessible, blood-based targets for monitoring or prevention of Alzheimer’s disease and related dementias among diverse communities of middle-aged adults.